Aging in Autism Spectrum Disorder: Outcomes and Indicators

Intentionally left blank Not required for PA-18-591 Attachment required for submission via grants.gov

Public health relevance
Intentionally left blank Not required for PA-18-591 Attachment required for submission via grants.gov